Organizational factors associated with quality of care for opioid use disorders among transition-age adults in Medicaid - Revision - Revision - 1 - Diversity Supplement

PROJECT SUMMARY
The parent grant for this supplement explores variation in quality of care for transition age adults
with opioid use disorder. TA adulthood—between ages 18 to 25—is a distinct and critical
developmental period where unique biological, psychological, and social changes are occurring.
SUD and mental health conditions are more prevalent in this age group than at other ages.
Effective treatment at this age has the potential for large long-term payoffs. Over the past
decade, there has been a large rise in the prevalence of opioid use disorders (OUD) among TA
adults. Yet, the treatment system for OUD performs poorly for TA adults: they are less likely to
obtain scientifically supported treatment and more likely to leave treatment early. The parent
study combines data from multiple sources, including Medicaid and a state registry of SUD
treatment episodes, to examine three aspects of OUD treatment quality for approximately
65,000 TA adults entering treatment for OUD between 2012 and 2025: 1) MOUD use; 2)
adherence to pharmacotherapy and retention in treatment; and 3) adverse events (e.g.,
overdoses). To guide our study, we employ a conceptual model that draws from the
Donabedian quality of care framework (Organizational Structure>Clinical Process>Outcome)
and from social ecology to examine program quality of OUD treatment for TA adults while
accounting for individual and community level factors associated with the ability of these
programs to deliver care. An important feature of this project is the close partnership between
the academic research team and leadership for the agency that regulates addiction treatment in
New York. Mr. Rentería’s professional development will be enhanced by participating in this
partnership between health services researchers and policy makers to bring scientific methods
to practice change.
Current progress. The parent award is in its first year of a five-year project. The multidisciplinary
and cross-institutional project team has formed, the analytical dataset is being developed, and
outreach has begun to develop and convene a stakeholder council to advise on the conduct of
the research. One emerging question stemming from early meetings of the investigative team is
about variation in beliefs, values, and practices of prescribers of MOUD for TA adults. The
decisions regarding medication administration among these prescribers may have significant
impact on the response to treatment among TA adults.

Public health relevance
PROJECT NARRATIVE Transition age adults (ages 18-25) with opioid use disorders are poorly served by the current treatment system for substance use disorders. This study will examine the variation in quality of treatment for opioid use disorders for this age cohort and examine multilevel factors—individual, community, treatment program—associated with higher quality care. The findings from this study will inform clinical decision making by patients and providers as well as public health responses to the rising tide of young adults seeking treatment for OUD.